Targeted degradation of CDK4 and 6 to overcome treatment resistance in breast cancer

Abstract
Although CDK4/6 inhibitors (in combination with an endocrine therapy) are the preferred systemic therapy for
treatment of patients with metastatic, Estrogen Receptor-positive (ER+) breast cancer (BC), development of
resistance to CDK4/6 inhibitors is universal. Therefore, development of novel therapeutic strategies to target
CDK4/6 inhibitor resistance remains an unmet clinical needs.
To probe the dependency of ER+ BC cells and tumors on CDK4 and 6 for growth, we profiled a panel of ER+
BC cell lines, patient-derived xenografts (PDXs) and primary tumors from ER+ BC patients for expression of
these proteins. We observed near universal expression of CDK4 but no detectable expression of CDK6 in ER+
BC samples. However, overexpression of CDK6 (and not CDK4) is a common mechanism of resistance to
CDK4/6 inhibitors in ER+ BC patients. Using a panel of ER+ BC cell lines engineered to overexpress CDK6, we
showed that CDK6 overexpression confers resistance to palbociclib although palbociclib completely blocked
phosphorylation of pRB in these cells. Furthermore, overexpression of a kinase-dead (K43M) mutant of CDK6
(referred to as CDK6-KD) was sufficient to confer palbociclib resistance both in vitro and in vivo. Our mechanistic
investigations revealed that CDK6 overexpression promotes transcriptional reprogramming of BC cells in a
kinase-independent fashion and that the non-kinase function of CDK6 is a key driver of palbociclib resistance.
Finally, we showed that CDK4/6-D, a CDK4/6-selective proteolysis targeting chimera (PROTAC), which causes
targeted degradation of CDK6 (and CDK4), and eliminates both kinase and non-kinase functions of CDK6, exerts
potent tumor growth inhibition in CDK6 high, palbociclib-resistant ER+ BC xenograft models.
Supported by our preliminary data, we hypothesize that high CDK6 in ER+ BC cells causes CDK4/6 inhibitor
resistance, at least in part, through kinase-independent transcriptional reprogramming, and that pharmacological
targeting of both the kinase and non-kinase of CDK6 is necessary to inhibit the growth of these tumors.
Specific Aim 1: To define the roles of kinase and non-kinase functions of CDK6 in conferring palbociclib
resistance in a panel of CDK6-high, palbociclib-resistant cell line- and patient-derived xenograft (PDX) models
of ER+ BC using advanced 3D genomic and machine learning approaches.
Specific aim 2: To evaluate the in vivo efficacy of a CDK4/6-selective degrader (CDK4/6-D) in a panel of CDK6-
high, palbociclib-resistant ER+ BC xenografts, both as a single agent and in combination with endocrine therapy.
Specific Aim 3: To evaluate the efficacy of CDK4/6-D in a panel of CDK6-high, palbociclib-resistant PDXs
engrafted in a unique NeoThy humanized mouse model, both as a single agent and in combination with
endocrine therapy and checkpoint inhibition.
Our novel therapeutic approach has the potential to improve clinical outcomes in many BC patients.

Public health relevance
Project Narrative Overexpression of CDK6 is a common mechanism of resistance to CDK4/6 inhibitors in breast cancer. In this study, we show that, in addition to its well established kinase-dependent role in regulating cell cycle, CDK6 also orchestrates transcriptional reprogramming in breast cancer cells through a kinase-independent function that confers palbociclib resistance. Thus, targeting both the kinase and non-kinase functions of CDK6 represents a novel strategy to overcome palbociclib resistance.